Compound Cardiovascular Activity Prediction Using Structural and Genomic Features

Project Summary
Unexpected cardiovascular activity plays a substantial role in therapeutic program failure leading to major loss
of patient life and research time. Therefore, it is imperative that steps be taken to understand and predict drug
cardiovascular activity. As the age of personalized medicine advances, the use of Gene Expression Signatures
(GES) has emerged as a new tool to describe biological processes. These GES consist of the quantitative levels
of mRNA expressed in a biological system as a result of a perturbation; however, they lack information about
underlying protein structure and function. It has been shown that Structural Gene Expression Signatures
(sGES), which integrate protein structure information derived from GES, produce reliable signatures that
capture cellular responses to perturbagens such as drugs. Specifically, preliminary results demonstrate how
these sGES capture underlying patterns that link compound structure with cardioactivity in cardyomyocites.
This preliminary data, combining computational and experimental work, was made possible by the outstanding
environment of scientific inquiry nurtured through the long-standing collaboration between this proposal's
sponsor and co-sponsor. The goal of this training is to hone skills that bridge the divide between informatics,
bench top experiments, and human health as well as develop fluency in scientific thinking that can be applied
to a future career as a physician scientist. The mentorship of this proposal's sponsors, the opportunities at
ISMMS to learn from diverse collaborations and experiences, as well as the scientific plan outlined in this
proposal all contribute to the strength of this training plan to achieve this goal. Specifically, this project will
expand the sGES tool through the addition of multiple features derived from structure and function, such as
secondary structure and protein disorder, and apply the resulting signatures to cardiovascular activity
understanding as well as prediction. The final sGES tool will be made publically available on a web server,
which has already been constructed. Next, profiles will be generated for compounds based on their signature,
structure, and recorded cardiovascular activity in the FDALabel database. The use of these profiles will be two
fold. The first will be as training data for an ensemble learning algorithm, which will predict drug structure
from signature and therefore provide a valuable first step toward generating de novo compounds from disease
signatures. The second use of these profiles will be to create a map linking chemical structure to cardiovascular
activity. The predicted cardiovascular activities from these computational aims will be experimentally validated
with cell based cardiotoxicity assays such as the hERG assay, which is a commonly used as a first line screen for
cardiovascular toxicity. Ultimately, the completion of this project will result in the development of useful,
validated, publically available tools for understanding as well as predicting cardiovascular activity and prepare
the investigator to conduct scientific research as a physician scientist.

Public health relevance
Narrative The inability to predict cardiovascular activity of compounds has lead to numerous drug failures. This project aims to decipher links between drug signature, structure, and cardiovascular activity through the application of cell based experiments, bioinformatics, and machine learning to genomic information. The resulting validated methods will broaden our understanding of the role of pharmacogenomics in drug development and provide a novel approach to cardiovascular activity prediction.